Bridging Network Science and Causal Inference to Improve Public Health Response to Outbreaks and Endemic Diseases

Understanding the dependencies among individuals with regard to disease status is critical to investigating
spread of communicable disease as well as effectiveness of mitigation strategies. Rather than assuming that
the members of a population of interest are fully mixed, as is commonly done with mass-action models in
infectious disease epidemiology, the network approach enables individual-level specification of contact
patterns by considering the structure of connections among the members of the population. By representing
individuals as nodes and contacts between them as edges, network representation of populations facilitates
the identification of individuals who drive epidemics and thereby provides insight into promising interventions to
control disease spread. Network science in its early days focused exclusively on static networks; hence, use of
network science methods to study disease spread was often limited to the study of dynamical processes on
static networks. Recent advances in epidemic control underscore the need to move research focus to dynamic
networks, and study of temporal networks has emerged as its own subfield. The growing literature on
dynamical processes on dynamic networks underscores a variety of challenges–for example,
nonpharmacological interventions, such as mask wearing and social distancing, promoted during the peak of
the COVID-19 pandemic. Factors that currently limit the public health benefit of network analyses include lack
of available network data (especially on dynamic networks) and lack of suitable quantitative methods for
uncovering network mechanisms, accommodating partially observed networks, and making causal inferences
from incomplete observational network data. The goal of the proposed project is to develop such methods in
order to increase the pace and accuracy of research in infectious diseases and endow the public health
community with these important tools. Our specific aims are the following. Aim 1: To identify individual-level
mechanisms for the formation and evolution of dynamic, fully observed person-to-person contact networks.
Aim 2: To develop Bayesian statistical inference methods for settings in which networks are only partially
observed. Aim 3: To develop methods that permit causal inferences on networks in settings where the
outcome of one participant may depend on the exposures, covariates, or outcomes of others. We subdivide the
final aim into two distinct components: Aim 3a: To develop a Bayesian approach for causal inference of
network effects; Aim 3b: To extend the approach of Aim 3a to allow for partially observed networks or networks
whose properties are known with error. We also propose to implement these methods in open-source software,
using a combination of R and Python, to facilitate their dissemination and adoption. We believe that the
research proposed here can help harness the type of network data we may realistically have available to
address the types of causal questions that are at the core of public health.

Public health relevance
Network models are used to gain a more precise understanding of human behavioral factors associated with the spread of infectious diseases to develop more effective interventions. Factors that currently limit the public health benefit of network analyses include lack of available network data (especially on dynamic networks) and lack of suitable quantitative methods for uncovering network mechanisms, accommodating partially observed networks, and making causal inferences. The goal of the proposed project is to develop such methods in order to increase the pace and accuracy of research and endow the public health community with these important tools.